HEALing Communities Study Data Coordinating Center

Project Summary/Abstract
Although preliminary evidence suggests increased acceptability for the use of fentanyl test strips (FTS),
significant gaps remain in understanding whether use of FTS reduces risk behaviors of people who use drugs
(PWUD). The relationship between the distribution of FTS and their uptake by PWUD also remains unclear.
Utilizing the existing HEALing Communities Study (HCS) infrastructure we will examine gaps in our
understanding of FTS use and distribution. Through an observational study with three research sites, we will
evaluate the individual-level overdose (OD) risk reduction associated with FTS use and an organizational-level
assessment of the operations for FTS distribution within select HCS communities.
The existing data coordination center (DCC) at RTI will assist the FTS Study in its goals. Our DCC has five
specific aims. We will enhance the scientific rigor of the study by facilitating the development of a uniform study
protocol that applies the best principles of study design and statistical methods to address the unique scientific
questions related to the relationship between the use of FTS, durability of FTS use, and drug OD risk reduction
behaviors (Aim 1). We will provide a research infrastructure that facilitates communication, coordination, and
consensus-building by providing centralized operational, administrative, and logistical support to facilitate
cross-site communication, enhance collaborative research, and foster consensus (Aim 2). We will maximize
efficiency with flexible data and study management, promote HEAL data harmonization and sharing, with
continuous real time monitoring of study progress, feasibility milestones, and data quality (Aim 3). We will
protect participant safety and study integrity by working with and reporting to the single IRB and the National
Institute of Drug Abuse (NIDA) (Aim 4). We will provide timely reporting, data analysis, and collaborate with
investigators on all consortium analyses and publications (Aim 5).
Our DCC team is led by multiple Principal Investigators—Drs. Emmanuel Oga, LaShawn Glasgow, and Gary
Zarkin—who are experienced leaders of multisite studies and experts in substance abuse, data harmonization,
program management, and consensus building; and Co-Investigator, Dr. Jon Zibbell. The broader team of
Core Leaders, key staff, and consultants brings robust scientific and implementation science skills interwoven
with a deep understanding of prevention science of opioid misuse and addiction. We offer proven
computational infrastructure and statistical expertise to support all the required data management and analysis
needs for this study. We are backed by RTI’s unsurpassed experience and proficiency—born from successful
leadership of over 40 other DCCs—to ensure that we support and accomplish the aims.

Public health relevance
Project Narrative Emerging evidence indicates increased acceptability for the use of fentanyl test strips (FTS) as a harm reduction method for reducing risk of overdose among people who use drugs (PWUD). Yet, there remains a lack of sufficient data about how PWUD use FTS and how organizations distribute them. As the Data Coordinating Center, RTI will support the FTS ancillary study on coordination, communication, and data infrastructural support for data collection, management, quality control, and analysis to enable a broader understanding of FTS use.